Per- and poly-fluoroalkyl substances (PFAS) in pregnancy vascular and placental dysfunction

ABSTRACT
Pregnancy-induced vascular adaptations, adequate placental vascularization, and optimal flux of nutrients
across the placenta to the fetus are critical to support fetal growth. Disruption in one or more of these
processes leads to fetal growth restriction (FGR). FGR affects up to 15% of all newborns, and no treatment is
available. The cause of FGR is not known, but the environmental exposure to per- and poly-fluoroalkyl
substances (PFAS) and its bioaccumulation in the placenta may hold important keys to understanding the
origins of the disease and the underlying causes of maternal organ dysfunction. Perfluorooctane sulfonate
(PFOS), a legacy PFAS, is the most produced and well studied PFAS. Elevated maternal PFOS is shown to be
associated with maternal vascular dysfunction and FGR in humans. Whether this increase in PFOS is directly
involved in endothelial dysfunction and manifestations of FGR is unknown. Our pilot studies show that elevated
PFOS in pregnant rats increases maternal blood pressure, blunts endothelial function, and decreases in
placental size, VEGF expression, and nutrient transport. Based on these findings, we hypothesize that
elevated PFOS levels impair maternal cardiovascular function and reduce placental vascularization and flux of
nutrients to lead to FGR. We will examine this premise in 3 aims employing in vivo animal studies, ex vivo
tissue-level functional analysis and in vitro molecular analyses. Aim 1 will first establish the functional effects of
elevated PFOS on systemic blood pressure and uterine artery blood flow and define the PFOS-mediated
signaling. To test the PFOS-mediated vascular mechanisms, EDHF, NO, and PGI2 relaxation pathways will be
determined. Also, the expression of eNOS and its activity state—signaling components of EDHF and PGI2
pathways as well as nitrate/nitrite and PGI2 production and changes in membrane potential—will be measured.
Then translational studies will test whether PFOS affects the endothelial pathways and mechanisms in
pregnant women by examining the effects in isolated omental and placental vessels. Aim 2 will examine
placental vascular effects. We will determine if elevated PFOS decreases growth, diameter, and length of
spiral arteries, central arterial canals, fetoplacental arterial branches, and umbilical arteries. We will also
measure the expression of pro- and anti-angiogenic factors in the placenta, and then determine if PFOS
disrupts signaling mechanisms in endothelial cells isolated from pregnant women. Aim 3 will examine placental
nutrient transport effects. We will determine if elevated PFOS decreases glucose, amino acid, and fatty acid
transport across the placenta to the fetus and measure the expression of nutrient transporters in the placenta.
Then, determine if PFOS disrupts nutrient transport in pregnant women by examining the effects in primary
trophoblasts. These results are expected to have an important impact because they will contribute
substantively to a mechanism-based understanding of PFOS's role in pregnancy complications and alert
environmental agencies to devise policies to curtail PFOS exposure to reproductive-age women.

Public health relevance
NARRATIVE Maternal blood vessels undergo dramatic adaptations to decrease blood pressure and increase uteroplacental perfusion to meet the metabolic demands of the fetus. The proposed studies will help define the role of environmental exposure to perfluorooctane sulfonate (PFOS) in blunting vascular relaxation, increasing blood pressure, and decreasing uteroplacental perfusion and nutrient transport to the fetus during pregnancy. These results will contribute substantively to a mechanism-based understanding of PFOS's role in pregnancy complications and alert environmental agencies to devise policies to curtail PFOS exposure to reproductive- age women.